Difficulties with Self-Control and High-Risk Alcohol Use in Young Adults

DESCRIPTION (provided by applicant): This application is for a Mentored Research Scientist Development Award (K01). The candidate, Robert Leeman, Ph.D., has a programmatic interest in high-risk alcohol use and difficulties with self-control, with a particular interest in the young adult population. Dr. Leeman aims, as a junior faculty member at Yale, to acquire skills to develop into an independent scientist in the field of alcohol research. The training and research plan enlists the mentorship and collaboration of Stephanie O'Malley, Ph.D., Professor of Psychiatry, the Director of the Division of Substance Abuse Research and the Clinical Core of the Yale Center for the Translational Neuroscience of Alcoholism (CTNA) and Marc Potenza, M.D., Ph.D., Associate Professor of Psychiatry and the Child Study Center and Director of the Yale Program for Research on Impulsivity and Impulse Control Disorders. The mentors-along with consultants, all of whom have international reputations in their fields-will assist Dr. Leeman in accomplishing his training goals, in completing the projects detailed in the research plan and in his progression toward becoming an independent researcher. Dr. Leeman's primary training goals for the K01 are 1) to enhance his skills in conducting alcohol administration research and 2) to develop specialized skills in data analytic techniques to model latent variables and to analyze prospective data. A secondary training goal is to learn more about the neurocircuitry implicated in trait and alcohol-induced disinhibition as well as the long-term alterations of neurocircuitry that typify alcoholism. The Research Plan consists of three interrelated studies that relate to Dr. Leeman's interests in alcohol use and self-control and will allow him to apply knowledge gained from the training proposed in the award: 1) testing structural equation models to assess associations among trait disinhibition, expectancies of alcohol's disinhibiting effects and impaired control over alcohol use and to assess these constructs as cross-sectional predictors of high-risk drinking; 2) a secondary data analysis to test disinhibition expectancies and impaired control over alcohol use as mediators of outcome in a clinical trial of naltrexone and BASICS counseling for heavy drinking reduction in young adults and 3) development and validation of a human alcohol self-administration paradigm designed to model impaired control over alcohol use. The proposed alcohol self-administration paradigm entails provision of disincentives for non-moderate alcohol use that disregards a controlled drinking guideline. The proposed research has the potential to inform our understanding of the ways in which various difficulties with self-control contribute to high-risk drinking. Results from the proposed research will provide preliminary data for an R01 application to be completed by Dr. Leeman during the award period. Completion of the proposed training and research would allow him to transition to independence as an investigator by the completion of this award and lay the groundwork for his long-term career goals.

Public health relevance
PUBLIC HEALTH RELEVANCE: Young adult heavy drinking is a significant public health concern. The candidate for this award requests training and proposes a research plan to progress toward independence as an investigator with focus on risk factors for and mechanisms underlying heavy drinking and alcohol-related problems in young adults. Knowledge about risk factors and underlying mechanisms can inform intervention approaches to reduce heavy drinking and alcohol-related problems in this population. Young adult heavy drinking is a significant public health concern. The candidate for this award requests training and proposes a research plan to progress toward independence as an investigator with focus on risk factors for and mechanisms underlying heavy drinking and alcohol-related problems in young adults. Knowledge about risk factors and underlying mechanisms can inform intervention approaches to reduce heavy drinking and alcohol-related problems in this population. __SpecificAimsTextDelimiter__ 10. Specific Aims The three projects described in this section focus on links between difficulties with self-control and high-risk alcohol use (i.e., heavy drinking and alcohol-related problems). Specifically, the studies explore disinhibition directly related to alcohol (i.e., impaired control over alcohol use and alcohol-induced disinhibition expectancies) and disinhibition at a trait level (e.g., impulsivity and sensation seeking). Project 1 will investigate relationships among self-reported trait disinhibition, alcohol-induced disinhibition expectancies and impaired control over alcohol use and test these constructs as predictors of binge drinking and alcohol-related problems in an undergraduate sample (N = 642). Impaired control and expectancies of alcohol's disinhibiting effects are hypothesized to mediate relationships between trait disinhibition and high-risk drinking. We also hypothesize that relationships between disinhibition expectancies and high-risk drinking and between impaired control and high-risk drinking apply to individuals who are high and low in trait disinhibition. Project 2 will utilize data from a double-blind, placebo controlled, clinical trial to test the efficacy of naltrexone plus Brief Alcohol Screening and Intervention for College Students (BASICS; Dimeff et al., 1999) for alcohol use reduction in young adults. The goal will be to test hypotheses that disinhibition expectancies and impaired control over alcohol use will mediate naltrexone's effects in reducing frequency of any drinking and heavy drinking. Mechanisms of naltrexone and elements of BASICS counseling suggest that this treatment may reduce impaired control and positive disinhibition expectancies (i.e., euphoric/social and sexual), which could, in turn, lead to reductions in drinking among the young adults in this study. The goal of Project 3 is to develop and validate a human alcohol self-administration paradigm of impaired control over alcohol use. When validated, future studies could use this paradigm to assess the efficacy of behavioral strategies or pharmacotherapies in bringing about moderate drinking and reducing impaired control.